Adolescent Markers of Depression and the Impact of Alcohol Use

PROJECT SUMMARY
This K23 award will allow Dr. Meruelo to become an expert on the relationship between adolescent
alcohol use and depression. During his training, he proposes to address that untreated alcohol use
disorder and depression lead to poor health outcomes ultimately affecting both quality and quantity of life.
Dr. Meruelo plans to use an innovative approach and multiple imaging techniques of the NCANDA
consortium in a longitudinal study to identify brain features that address the temporal relationship
between these two comorbid disorders. Identifying risk factors is of critical importance to anticipating
which individuals would benefit from earlier interventions and treatment to reduce morbidity and mortality
directly. The award will provide him the support needed to develop expertise in four areas: (1) adolescent
alcohol use and major depression, (2) neuroimaging and brain development, (3) advanced statistics, and
(4) execution of longitudinal studies.
To achieve the K23's goals, Dr. Meruelo has assembled an expert multidisciplinary team. Drs Tapert
and Brown will facilitate guidance and access to the activities of and data from a longitudinal study
conducted by the
National Consortium on Alcohol and Neurodevelopment in Adolescence (NCANDA) to
address one of NIAAA's major initiatives. They will also provide expertise in adolescent alcohol use and
comorbid depression and on planning, recruiting, and implementing longitudinal study designs with
adolescents, as well as career and mentorship on the responsible conduct of research. Dr. Schuckit will
provide expertise on comorbidity between alcohol and depression and other career development skills.
Dr. Thomas will provide hands-on training in advanced longitudinal analyses of associated data.
NCANDA data is already available to begin addressing central questions of the proposal. At Year 1 or 2,
clinically significant depression has been identified in 61 participants after a healthy prior year following a non-
depressed baseline. Also identified are those using moderate or heavy alcohol use at baseline, year 1, and
year 2 of the study in 164, 223 and 283 participants, respectively. Year 3 data will be available January 2018.
The K23 research specific aims are: (Aim 1) to identify whether any adolescent alcohol use is more
likely to lead to long-term depression, or if long-term depression is seen more often after subsequent
increases in alcohol use, or both, using latent difference score models to distinguish cause and effect.
The common factor of stress and subsequent depression and/or substance use is critical to
understanding their impact on growing adolescents, and (Aim 2) to identify morphometrics that predict the
development of depression in healthy adolescents using: (a) Naïve Bayesian classifier, and (b) principal
component analysis with subsequent hierarchical linear regression.

Public health relevance
PROJECT NARRATIVE Twenty percent of teens suffer from depression before reaching adulthood and up to half of those also are engaged in using alcohol. This project will establish how the development of depression and alcohol use are related, in addition to ways to predict the onset of depression in healthy adolescents. By identifying temporal precedence in the relationship between alcohol use and depression, and predictors of when depression is more likely to occur, we will be in a position to improve treatment of those likely to suffer from depression and struggle with control over alcohol use, reducing costs and improving quality of life for patients, our health system, and society.